Molecular control of chondrocyte hypertrophy: an evolutionary approach

Project Summary
In mammals, cartilage is predominantly an embryonic tissue: the vast majority of cartilage is replaced by bone
during the processes of hypertrophy and ossification, with cartilage persisting in relatively few places within the
adult skeleton (e.g. in joints, as articular cartilage). Articular cartilage is an aneural, avascular tissue with very
limited capacity for spontaneous repair, hence the prevalence in humans of cartilage pathologies like
osteoarthritis. In contrast, cartilaginous fishes (sharks, skates, and rays) have undergone an evolutionary loss
of bone, instead possessing a skeleton that is composed entirely of pre-hypertrophic cartilage, and that
remains cartilaginous throughout life. Understanding how cartilaginous fishes arrest skeletal development prior
to chondrocyte hypertrophy will shed new light on transcriptional features that could be employed for in vitro
engineering of stable chondrocytes for the treatment of human cartilage injuries.
Stem cell-based approaches for the treatment of articular cartilage injuries are currently hindered by the
relative instability of mammalian cartilage cells (chondrocytes) in vitro and upon implantation into an injury site.
In this project, the molecular development of cartilage in the little skate (Leucoraja erinacea) will be studied to
discover gene expression correlates of their permanent cartilaginous skeleton. This project will begin with the
use of single-cell RNA-sequencing to identify genes that are differentially expressed between
developing and differentiated skate and mammalian chondrocytes (Aim 1), and that may underlie arrest
prior to hypertrophy in the former. ATAC-seq and comparative genomic approaches will then be used to
test for variation in non-coding regions (i.e. putative enhancers) that might account for divergent gene
expression during skate and mammalian skeletogeneis (Aim 2). Finally, skate-inspired molecular
manipulations (CRISPR/Cas9 genome editing and/or transgenesis) will be incorporated in an in vitro
model of mammalian skeletogenesis, in order to achieve a permanent and stable chondrocyte cell state
from mammalian mesenchymal progenitors (Aim 3).
This project will capitalize on the unique properties of the skate skeleton, and on the biological resources,
facilities, and expertise that are available at the Marine Biological Laboratory in Woods Hole. By taking an
evolution-inspired tissue engineering approach, this project will contribute to the development of novel in vitro
techniques for cartilage engineering and for the treatment of mammalian skeletal pathologies.

Public health relevance
Project Narrative Cell-based therapies for cartilage injury and osteoarthritis rely largely on in vitro engineering of replacement cartilage from mesenchymal progenitors, but are plagued by the instability of the cartilage cell (chondrocyte) phenotype: mammalian stem-cell derived chondrocytes tend to either hypertrophy or dedifferentiate when implanted into a patient. However, cartilaginous fishes (sharks, skates, and rays) possess a skeleton that is composed entirely of pre-hypertrophic cartilage, and that remains cartilaginous throughout life. In this study, I will use single-cell RNA-sequencing and comparative genomics to identify gene expression correlates of permanent pre-hypertrophic cartilage in the skate (Leucoraja erinacea), and use skate-inspired molecular manipulations to achieve and optimize a stable chondrocyte cell state from mammalian mesenchymal progenitors.